Addressing Tetrachloroethylene Exposure in an Impacted Community: Residents' Concerns, Neurotoxic Effects, and Exposure Reduction

Project Summary
We propose to develop a community engaged research program in Martinsville, IN, a community of 11,000
people that overlays four groundwater contamination sites, including a U.S. Environmental Protection Agency-
designated Superfund site. The total size of the groundwater contamination is over 60 acres and lies within a
single aquifer. The contaminants are chlorinated volatile organic compounds (CVOCs), primarily
tetrachloroethylene (PCE) and trichloroethylene (TCE), thought to originate from several dry cleaning and
metal degreasing operations. An activated carbon filtration system has been in operation since 2005 to remove
PCE/COVCs from the municipal water, which now meets EPA drinking water standards. However, a recent
report from the Agency for Toxic Substances and Disease Registry concludes that people’s health may be
harmed by breathing indoor air contaminated via vapor intrusion, the migration of volatile compounds from
contaminated groundwater and soil into buildings above. The long-term goal of our research is to understand
health effects of PCE exposure in communities, and to empower community members’ participation in
environmental health decision-making. The project will be led by a transdisciplinary academic team in a strong
partnership with two community based organizations. This team will partner with an existing, engaged
Community Advisory Board (CAB), to accomplish three aims. Aim 1 will assess the community’s concerns and
perceptions about the contamination and associated health risks, and how that changes across the 5-year
project. Aim 2 will quantify current exposure to PCE/CVOCs in exhaled breath and indoor air from 300
residents using a cutting edge assessment tool, proton transfer reaction time-of-flight mass spectrometer
(PTR-TOF-MS). Through modeling we will estimate cumulative exposures in residents and investigate
associations of CVOC mixtures with visual and cognitive functions, which are hypothesized to be a sensitive
non-cancer endpoint for PCE exposure. We will also address the community’s concerns about elevated cancer
rates using Indiana state cancer registry data. In Aim 3, we will design and implement a targeted educational
campaign to promote PCE/CVOC testing and installation of mitigation systems when residential contamination
levels exceed exposure limits, with a focus on promoting property owners’ and landlords’ participation in vapor
intrusion testing and remediation activities. With the CAB, we will co-design the action plan, identifying and
responding to emerging barriers, through a Developmental Evaluation (DE) process utilizing a Theory of
Change (TOC) model informed by the evaluation team’s qualitative and quantitative analysis of data on
stakeholder concerns and responses. Throughout the process of community assessment and education, we
will evaluate the effectiveness of the process, identifying pathways for moving from research to effective
actions.

Public health relevance
Project Narrative This project will work with the community of Martinsville, IN, which is concerned about the health effects of a long-standing contamination of their groundwater by tetrachloroethylene and trichloroethylene. We will measure contamination in residents and their homes, study the impact of the contaminants on visual and neurocognitive limitations, and compare cancer rates in Martinsville to county and state rates. This information will help us co-design with the community an educational campaign reduce exposure to contaminants by promoting testing of homes for indoor air contamination and installation of mitigation systems when residential contamination levels exceed exposure limits.